MR Imaging of Bioscaffold-Induced Neural Progenitor Migration

Abstract
The regeneration of brain tissue has been considered one of the greatest challenges for
regenerative medicine. Implantation of an extracellular matrix (ECM) hydrogel can
produce de novo brain tissue by attracting endogenous neural progenitors into a tissue
cavity. These neural progenitors originate in the subventricular zone (SVZ), one of the few
neurogenic sites in the adult brain. Initially, neural progenitors migrate in the peri-infarct-
damaged tissue before invading the bioscaffold. However, little is known about the route
or time-course of migration of these cells. The objective of this application is to develop a
non-invasive MR imaging paradigm that affords the tracking of neural progenitors from the
SVZ to the bioscaffold. Specifically, we here aim to: 1) develop and optimize contrast agent
to label endogenous neural progenitor cells, 2) to non-invasively track the migration of
neural progenitors and 3) to determine the temporal dynamics of neural progenitors
responding to a hydrogel implant. Achieving an in vivo visualization of neural progenitor
migrations will aid us to understand the contribution of neurogenesis to brain tissue
regeneration, but also to devise novel strategies that can manipulate this process.

Public health relevance
Narrative Hydrogels derived from extracellular matrix induce brain tissue regeneration by attracting brain cells into the stroke cavity. However, little is known about the spatio-temporal characteristics of neural progneitors migrating from the subventricular zone to the bioscaffold. A major limitation to map and understand the contribution of neurogenesis to brain tissue regeneration is the lack of in vivo imaging tools that can be utilized to visualize this process. We here described a novel method in which we inject gadolinium- gold nanoparticles into the lateral ventricle to tag newly born neural progenitors and track their migration using T1-weighted MRI. The positive signal emanating from these cells can unequivocally be attributed to labeled cells and allow us to increase spatial resolution to resolve a very detailed brain anatomy, specifically the tissue-bioscaffold interface. We further here propose to conduct experiments that will exploit this in vivo MR imaging to study the role neurogenesis plays in brain tissue regeneration. These studies will dramatically improve our ability to further develop bioscaffold for tissue regeneration.